Toll-like receptor mediated regulation of effector and memory CD4 T cell response

DESCRIPTION (provided by applicant): The Toll-like receptors (TLRs) are a family of pattern recognition receptors (PRRs) that recognize a diverse set of Pathogen Associated Molecular Patterns (PAMPs) from different classes of microbes and play an essential role in innate immune defense of the host. In addition, TLRs have been shown to play a critical role in induction of adaptive immune responses. Recognition of PAMPs by TLRs on dendritic cells (DCs) leads to DC maturation, a process that involves enhanced expression of MHC and co-stimulatory molecules as well as migration to the draining lymph nodes to prime naive T cells. TLR activation also leads to production of pro-inflammatory cytokines that contribute to CD4 T cell activation by overcoming Treg mediated suppression. Notably, TLR expression is not limited to DCs. In addition to cells of myeloid origin such as DCs and macrophages, other cells such as neutrophils, epithelial cells, fibroblasts, B lymphocytes and T lymphocytes have been shown to express functional TLRs. Although the outcome of TLR activation in all of these cell types is quite different, their individual contribution to the activation of naive CD4 T cells is not well understood. The overall goals of this study are to characterize TLR dependent mechanisms that control activation of naive CD4 T cells and their differentiation into long lived memory cells. Three specific aims are proposed to study the role of TLRs in controlling adaptive immunity. Aim 1 will characterize the role of different TLR expressing cells in naive CD4 T cell activation. Aim 2 will analyze the contribution of cytokines secreted by DCs, particularly Interleukin-1 and Interleukin-6, to CD4 T cell activation in vivo. Aim 3 proposes to understand the mechanisms by which TLR activation of DCs contributes to generation of CD4 T cell memory. Together these studies will yield novel insights into how recognition of pathogens via TLRs shapes CD4 T cell responses and will lead to better understanding of the mechanisms of innate control of adaptive immune responses in vivo. Furthermore, this work will aid in designing effective vaccine formulations for prophylactic vaccinations.

Public health relevance
PUBLIC HEALTH RELEVANCE: Humans and other multicellular organisms are exposed to a wide variety of different pathogens. The immune system has specialized receptors called Toll-like receptors (TLRs) to recognize structural and metabolic components of pathogenic microbes. This recognition is important for immediate defense of the host by the innate immune system. Long-term protection from re-infection however requires activation of pathogen specific T cells. T cell activation has been shown to be dependent on prior activation of TLRs on the cells of the innate immune system, namely dendritic cells. In this proposal, we will study the mechanisms by which TLR activation in dendritic cells contributes to induction of long- term protective immunity by T cells. The knowledge acquired from these studies will aid in development of new vaccination strategies against pathogens Project Narrative Humans and other multicellular organisms are exposed to a wide variety of different pathogens. The immune system has specialized receptors called Toll-like receptors (TLRs) to recognize structural and metabolic components of pathogenic microbes. This recognition is important for immediate defense of the host by the innate immune system. Long-term protection from re-infection however requires activation of pathogen specific T cells. T cell activation has been shown to be dependent on prior activation of TLRs on the cells of the innate immune system, namely dendritic cells. In this proposal, we will study the mechanisms by which TLR activation in dendritic cells contributes to induction of long- term protective immunity by T cells. The knowledge acquired from these studies will aid in development of new vaccination strategies against pathogens __SpecificAimsTextDelimiter__ A. Specific Aims The discovery of pattern recognition receptors (PRRs)(1) has led to greater understanding of the mechanisms of induction of adaptive immune responses. Several studies have now demonstrated that optimal induction of T cell responses requires activation of PRRs on antigen presenting cells such as dendritic cells (DCs) and macrophages(2-6). Toll-like receptors (TLRs) are critical for activation of innate immune pathways and are also essential for induction of adaptive immune responses(3, 6). The overall goal of this proposal is to characterize TLR-dependent mechanisms that control the induction of effector CD4 T cells, their commitment to IFN-gamma producing Th1 T cells or IL-17 producing Th17 cells, and their differentiation into memory T cells. These goals are based on preliminary studies charactering the role of DC secreted cytokines in T cell differentiation and a central hypothesis that naïve CD4 T cell activation is insufficient for the generation of long lived memory T cells in the absence of MyD88, a critical TLR signaling adapter. To address the principal question of the requirements for CD4 T cell activation, effector generation, and memory differentiation we wish to: 1) Characterize the role of different TLR expressing cells in naïve CD4 T cell activation and effector generation; 2) Analyze the contribution of cytokines, particularly IL-1 and IL-6, secreted by DCs to naïve CD4 T cell activation and effector differentiation; and 3) Understand the mechanisms by which TLR activation of DCs contributes to the generation of CD4 T cell memory. Specific Aim 1: Characterize the role of different TLR expressing cells in naïve CD4 T cell activation. We wish to analyze the contribution of TLR signaling in different cell types to naïve T cell activation and differentiation in vivo. We will (A) Generate mice with the critical TLR signaling adapter MyD88 expressed in specific cell types such as Dendritic cells, B lymphocytes and T lymphocytes; (B) Investigate how TLR activation in DCs alone influences CD4 T cell activation and differentiation in response to various TLR ligands; and (C) Investigate CD4 T cell responses and B cell responses in vivo when only B cells can signal through the adapter MyD88. Specific Aim 2: Analyze the contribution of cytokines secreted by DCs, particularly Interleukin-6 and Interleukin-1, to CD4 T cell activation and differentiation. The induction of MHC Class II and costimulation on DCs is not sufficient for primary T cell activation. DCs also need to secrete IL-6 to overcome Treg mediated suppression. In addition we find that IL-1 mediated MyD88 dependent signaling in T cells is critical for Th17 commitment. We also find that both IL-1 and IL-6 are necessary for Th17 lineage commitment in the lamina propria of the gut. To examine the role of IL-1 and IL-6 in T cell activation and differentiation we will (A) Generate mice with abrogated IL-6 signaling in CD4 T cells; and (B) Determine the consequences of T cell activation in the absence of IL-6 signaling in T cells. (C) Understand the molecular mechanisms of T cell differentiation induced by IL-1 and IL-6 at different anatomical sites. Specific Aim 3: Understand the mechanisms by which TLR activation of DCs contributes to the generation of CD4 T cell memory. TLR signaling in DCs leads to maturation as well as cytokine production. We have demonstrated that DC maturation in the absence of cytokine production can induce effector T cell activation without leading to generation of memory. We will (A) Develop models to study in vivo CD4 T cell activation; (B) Determine the fate of T cells under different DC activation conditions; and (C) Identify MyD88 dependent signals necessary for the induction of memory CD4 T cells.